Mechanisms of Cholinergic Signaling in the Inferior Colliculus

Our long-term goal is to determine how cholinergic signaling drives adaptive sound processing in the auditory
midbrain and how this computational flexibility is altered in auditory gating disorders, hearing loss, and aging.
As the midbrain link between the auditory brainstem and forebrain, the inferior colliculus (IC) is a critical
processing center that influences which auditory information gets presented to the forebrain. Computations in
the IC are modulated by cholinergic projections from brainstem cholinergic systems, including a dense
projection from the pedunculopontine tegmentum (PPT). PPT neurons convey information about states of
arousal, rewards, and the salience of sensory stimuli, including sounds. While previous in vivo studies have
shown that cholinergic drugs elicit diverse effects on IC neurons and that cholinergic signaling can drive
plasticity in the IC, the cellular and synaptic logic of cholinergic modulation in the IC have remained largely
unknown. This gap in knowledge has persisted due to the technical obstacles created by the diversity of
neuron types and convergence of ascending and descending pathways in the IC. This is a critical gap in
knowledge because understanding how cholinergic signaling influences specific populations of IC neurons and
their synaptic inputs is a prerequisite to understanding how cholinergic signaling links changes in internal and
external states to changes in auditory processing. We have recently overcome previous obstacles to progress
by developing molecular genetic techniques to label and manipulate specific populations of IC neurons and
their sources of synaptic input. Based on our past and preliminary data, the current proposal tests the overall
hypothesis that the effects of cholinergic signaling in the IC are largely determined by two factors: (1) the
muscarinic and nicotinic acetylcholine receptors expressed in specific populations of IC neurons and their
synaptic inputs and (2) the subcellular location and timing of acetylcholine release. We propose four aims to
test this hypothesis. In Aim 1, we use pharmacology and patch clamp recordings targeted to fluorescently
labeled populations of IC neurons to determine cellular mechanisms of cholinergic signaling in distinct
populations of excitatory and inhibitory IC neurons. In Aim 2, we combine optogenetic circuit mapping with
pharmacology and patch clamp recordings to determine how muscarinic signaling modulates specific sources
of synaptic input to the IC. In Aim 3, we use electron microscopy to identify ultrastructural relationships
between cholinergic boutons and IC neurons. In Aim 4, we use two-photon Ca2+ imaging in awake mice to
determine how and when cholinergic axons from the PPT respond to auditory stimuli. The proposed studies
will provide a functional and ultrastructural map of how cholinergic signaling alters excitability in distinct
populations of IC neurons and their synaptic inputs. The fundamental insights gained will be essential to
guiding and interpreting future in vivo and behavioral investigations into cholinergic effects on auditory
processing in the IC in normal and disordered conditions.

Public health relevance
Project Narrative Acetylcholine is a neurotransmitter that plays critical roles in normal hearing, helping us hear in quiet or noisy environments throughout our lives. Understanding these roles is critical for developing approaches to help people with age-related hearing loss, difficulty understanding speech in noisy environments, learning to hear with cochlear implants or coping with hearing dysfunctions in disorders such as autism or schizophrenia. The present proposal will answer critical questions about the cellular and circuit mechanisms that allow acetylcholine to support hearing.